microRNAs in Prostate-derived Exosomes as Prognostic Biomarkers and Mediators of Intercellular Communication

PROJECT SUMMARY/ABSTRACT
Compared to other cancers, the treatment of prostate cancer (PCa) poses a unique problem due to its high
prevalence of indolent disease and high rates of treatment morbidity. PCa is the most common cancer diagnosis
and the second leading cause of cancer-related mortality among US men, but 42% of US men age 50 or older
that died from other causes were found to have PCa in autopsy studies. Therefore, it is essential for clinicians to
accurately determine which patients will progress to lethal, metastatic PCa and which will not. Definitive
diagnosis and risk stratification is based off of multi-core biopsy results. However, PCa is often multifocal with
heterogeneous tumors, and the biopsy may miss areas that contain aggressive tumor. This uncertainty has led
to the over-treatment of low-risk PCa. Therefore, there is an urgent clinical need for accurate pre-intervention
PCa prognostic testing so that clinicians can treat high-risk patients but spare low-risk patients from the definitive
treatment morbidities. To address this clinical need, the first objective of this proposal is to discover and
characterize prognostic serum exosomal microRNAs (miRs) of prostatic origin. Exosomes are lipid-bilayer
vesicles that are secreted from cells and function in intercellular communication but have been exploited for their
potential prognostic value. These experiments capitalize on a pretreatment PCa sera cohort collected for a
previously funded study. Our goal is to utilize exosomes to develop a sensitive and specific prognostic test for
PCa. Previously published data suggests a prognostic role for prostate miRs, which are selectively loaded into
these vesicles, so there may be a population of miRs in circulating exosomes that are specific to PCa.
In addition to the prognostic potential of exosomal miRs, these vesicles have biological functions in cell-to-
cell communication. Furthermore, exosomes have been implicated in tumor progression and metastasis in
multiple cancers, including PCa. The most common form of PCa arises from the epithelial cells (PrE) of the
glandular acini, which are surrounded by a fibromuscular stroma. The stroma functions to support epithelial
growth and differentiation in the normal prostate but becomes tumor-promoting in PCa. These tumor-promoting
stromal cells are termed cancer-associated fibroblasts (CAF). The second objective of this proposal is to
elucidate the biological role of microRNAs in exosomes released from CAF on prostate epithelial cell
aggressiveness. Human primary prostate epithelial and stromal cells derived from radical prostatectomy
surgery tissue will be used as a model system to determine the changes in epithelial cell growth, proliferation,
and cytokine production after treatment with exosomes from CAF. The miRs within the exosomes released from
CAF will be knocked down or overexpressed to determine the mechanism of exosome action on PrE cells.
This project uses patient-derived models in a translational and multi-disciplinary approach to develop a non-
invasive serum exosome miR test for PCa prognosis and to determine the tumor-promoting effects of miRs
released from CAF.

Public health relevance
PROJECT NARRATIVE Prostate cancer (PCa), the most common cancer diagnosis and the second leading cause of cancer-related deaths among US men, is definitively diagnosed by random sampling of the prostate tissue by biopsy. The uncertainty associated with the biopsy procedure has led to problems with the over-treatment of PCa and highlights the need for a prognostic test that is not biased by sampling site. Circulating extracellular vesicles released by the prostate into patient serum will be utilized to develop a noninvasive, prognostic blood test for PCa, and extracellular vesicles released within the local prostate microenvironment will be studied to determine their contribution to PCa progression.